Building a Systematic, Comprehensive Mammalian Cell Fate Map

PROJECT SUMMARY
Cell fate maps are immensely powerful. They illuminate the pathways of differentiation and showcase the
dynamics of and coordination by cells to achieve complex biological structures. Accordingly, a sufficiently high-
resolution fate map of mammalian development would function as a guide to investigate factors that direct
these processes, and serve as an invaluable tool to generate and evaluate in vitro models and design cellular
therapies. The need for cellular therapies, including agents that might replace or repair damaged tissue or
organs, are becoming more urgent as the population ages. Until recently, lineage tracing in mammals relied
on techniques with limited precision, scope, and ability for new discovery. It is not surprisingly then that
fundamental questions, such as how cells move from pluripotency to more restricted cells types, remain
opaque. This project aims to address those questions by building a comprehensive catalogue of mammalian
differentiation. Leveraging recent innovations in single-cell RNA-sequencing and mammalian genome editing
using CRISPR-Cas9, this project seeks to establish a systematic, evolving lineage tracing platform capable of
recording mammalian processes. Simultaneous capture of single cell transcriptomes along with lineage
information facilitates the ability to link a cell’s current state with a piece of its history. An essential component
to this technology is a complementary computational infrastructure for processing and analyzing data. To find
differentiation pathways stemming from pluripotency, the lineage tracing platform will be applied to an in vitro
model of mouse development, gastruloids. Gastruloids form from the aggregation of mouse embryonic stem
cells and faithfully mimic many features of mammalian embryogenesis. Moreover, gastruloids are a well-
defined, tractable model enabling higher throughput studies in a cost-effective manner. To interpret data
produced from the lineage tracing experiments, a hidden Markov model is proposed to integrate information
across data sets and identify differentiation trajectories. Importantly, multiple trajectories may be discovered
for a given cell type showcasing the unbiased, data driven property of this technology. Finally, the modes by
which the lineage tracing platform may be used to identify genetic regulators and to inform cell type
manipulation in vitro are discussed.

Public health relevance
Project Narrative Cell fate maps, which chart the pathways of differentiation and showcase the dynamics of and coordination by cells to achieve complex biological structures, are immensely powerful – yet the mammalian cell fate map has remained elusive. A sufficiently detailed fate map would reveal the processes by which cells go from stem cells to specific cell types, such as neurons or muscle, providing invaluable clues to make these cells in a dish for future cellular therapies, such as for spinal cord injury, Parkinson’s disease, and diabetes. This project utilizes a CRISPR-based lineage tracing technology to systematically characterize differentiation pathways and aims to use that information to invent protocols for making different cell types in vitro.